MECHANISM OF PRODUCTION OF EXPERIMENTAL ALLERGIC ENCEPHALOMYELITIS

Studies regarding Fl mice provide valuable information regarding the influence of an immunologically heterozygous host on various aspects of disease. Results presented here demonstrate that T-cell lines obtained from SJL/J X PL/J (Fl) mice immunized with myelin basic protein (MBP) fragment 1-20 passively transferred experimental allergic encephalomyelitis (EAE) into naive Fl recipient mice. Splenic T-cells obtained from recipient mice after relapses could be cultured with either PL of Fl macrophages and passively transfer EAE. However, the same splenic T-cells cultured with SJL macrophages failed to transfer the disease. The expression of both parental la haplotypes (las and lau) by splenic macrophages was observed after treatment with interferon-gamma (IFN-gamma). However, a significantly greater degree of proliferation was obtained when Fl lymphocytes were incubated with either: (a) peptide fragment 120 as opposed to 9O-lOl; or (b) PL macrophages as opposed to SJL macrophages. The lack of a codominant response in the animals thus does not appear to be related to a variable degree of la haplotype expression,. The preferential response to lau and fragment 1-20 may be due to the strong interaction (high association constant) between lau and this antigenic determinant. Experiments examining the role of IL-2 receptor-bearing cells in EAE demonstrated that treatment of mice with the chimera protein, IL-2-PE40, inhibited inflammation, demyelination, and clinical manifestations of adoptively transferred EAE.